Elucidating prostate cancer risk mechanisms through large-scale cistrome wide association studies

PROJECT SUMMARY/ABSTRACT
In stark contrast to Mendelian disorders, the majority of complex trait-associated common variants map to
non-protein coding regions. Since there is a less well-developed genetic code for the much larger non-
protein coding portion of the genome, identifying the gene(s) and causal alleles underlying non-
Mendelian/complex traits presents a challenge. Given the rapidity with which genome wide association
studies (GWAS) are discovering regions associated with complex traits, causal allele and susceptibility
gene identification have become severe bottlenecks. The overall goal of this proposal is to outline a
rigorous and comprehensive strategy to discover functionally causal variants and their target genes. While
the proposal focuses on prostate cancer, the strategies can be applied to any non-protein coding locus.
The central hypothesis is that cancer risk loci are regulatory elements. Recent data convincingly
demonstrate that GWAS loci are enriched for regulatory elements. Regulatory elements control the level of
expression of genes. Causal variants are difficult to discover because the scientific community is less adept
at annotating the non-protein coding portion of the genome. This proposal seeks to develop a novel
computational and statistical framework to prioritize candidate causal variants and then to experimentally
validate these predictions. The proposal will jointly model quantitative trait loci (QTL) and allelic imbalance
(AI) signals in epigenetic data (ChIP-seq and ATAC-seq) and transcripts (RNA-seq) in a novel framework
that we term cistrome wide association studies (CWAS). The most significant CWAS loci will be subjected
to epigenome and genome editing to functionally characterize and identify causal variants.
Aim 1 will utilize novel experimental methods to create the large-scale datasets that will inform Aim 2. The
ultimate goal of Aim 1 is to perform H3K27 acetylation, and AR chromatin immunoprecipitation and high-
throughput sequencing (ChIP-seq) to annotate active enhancers, Assay for Transposase-Accessible
Chromatin (ATAC-seq) to identify open chromatin, and RNA-seq. All of these data will be subjected to target
enrichment at a predefined set of variants, which will enable the rigorous and systematic measurement of AI
at heterozygote sites. Aim 2 will utilize these data in a structured framework to computationally identify
statistically significant CWAS prostate risk loci that. These loci will be experimentally tested in Aim 3 where
Clustered Regularly Interspaced Short Palindromic Repeats (CRISPR) evaluation of the candidate
causal variants will be performed.
At the completion of this project, we fully anticipate that we will have begun to unravel the causal (i.e.,
pathogenic) variants that initiate human prostate cancer. Discovering the mechanisms underlying human
traits will not only inform the biology of disease, but may also reveal opportunities to more rationally
intervene in treatment and prevention.

Public health relevance
Project Narrative To date, most genetic risk factors for complex traits are located outside of known genes. This proposal focuses on developing rigorous strategies for identifying the actual causal variants underlying complex traits using novel and powerful methods. Employing these strategies will lead to a more profound understanding of the genetic mechanisms that drive disease risk.